Neurology of Effortful Neutralization of Threat in Obsessive-Compulsive Disorder

Obsessive-compulsive disorder (OCD) confers substantial individual and societal burden, and first-line
treatments are only effective in some of cases. One roadblock to treatment improvement is limited
understanding of compulsions, OCD’s characteristic behavioral patterns, which maintain distress and
contribute substantially to functional impairment. Experimental research into the psychological and neural basis
of compulsions is critically needed to enable the development of more effective treatment approaches. Existing
research on the neurobiology of OCD has found increased activity and hyperconnectivity in cortico-striatothalamo-
cortical (CSTC) circuitry, involving the orbitofrontal cortex, cingulate cortex, and striatum, at rest and in
response to affective and attentional tasks. However, findings have been mixed, perhaps in part due to the
heterogeneity of tasks that are presumed to mirror OCD-relevant processes. Advances in the understanding of
the basic neural mechanisms of threat-related behavior offer a promising path forward. Experimental research
has identified neural circuitry implicated in a wide range of defensive behaviors that protect against threats of
varying severity, predictability, and imminence. This literature has largely focused on active avoidance, in
which the individual moves away from the source of perceived threat, and passive avoidance, in which the
individual withholds an action to avoid encountering a perceived threat. However, compulsions in OCD are
distinct from active and passive avoidance in that they consist of repetitive, often highly effortful behavior
aimed at neutralizing a perceived threat, a phenomenon which has received limited attention to date. This is a
significant omission, given that compulsions contribute substantially to distress and impairment. To address
this gap, we propose a cross-sectional, task-based neuroimaging approach investigate behavioral and neural
biomarkers related to effortful neutralization of threat (ENT) in OCD. Individuals with OCD (n=35) and healthy
comparison individuals with no psychiatric diagnoses (HC; n=35) will complete a novel fMRI paradigm
developed by the RPL, the Tap-To-Safety (TTS) task, which is the first to directly elicit repetitive, effortful,
threat-neutralizing behavior. The task will assess ENT in various threat contexts, and will measure neural
activity associated with stimulus onset and decision-making. We hypothesize that individuals with OCD will
demonstrate excessive neutralization behavior during the task, as well as heightened activity in and
connectivity within CTSC circuitry during the task. The RPL is currently conducting a funded pilot study with
healthy participants to inform task development; the aims of the current proposal therefore focus on identifying
OCD-specific patterns of behavior and neural activity associated with ENT. The ultimate aim is to establish
foundational knowledge regarding decision-making in OCD for future research involving treatment outcome
prediction and novel treatment development.